Synthetic System for Neuron Subtype- and Context-Specific Subcellular RNA/Protein Manipulation and Bioactive Delivery

We propose to develop a synthetic biological system to manipulate subcellular RNAs and proteins in growth
cones or synapses of subtype- and context-specific neurons. This system has both direct, powerful near-term
experimental-investigative potential and future potential toward novel, uniquely specific forms of therapeutics/
bioactive delivery. The systems enable unique forms of subcellular functional investigation in subtype- and stage-
specific neuronal circuitry, offering generalizable modularity for manipulation of RNA and/or protein localized
to developing growth cones during circuit formation and to presynaptic compartments in maturing and mature
circuitry. Subcellular functions of proteins regulating connectivity and (dys)function of subtype-specific circuitry
are poorly understood. Based on successful preliminary studies, we propose to develop these tools for in vivo
perturbation of molecular abundances by integrating subcellular localization motifs with inducible gene
expression systems. This system will enable discovery of RNAs/proteins that function subcellularly to control
overall organization, precision, and function of distinct neural circuits, and how they are dysregulated in disease.
We aim to integrate motifs that selectively traffick proteins to GCs and/or presynapses with an inducible
gene expression system, enabling subcellular-specific overexpression via direct motif fusion, and knockdown
via motif fusion to hfCas13d, a refined mRNA degrader. We will use data from recently developed experimental
and analytical approaches purifying subtype-specific GCs or presynapses and their parent somata or nuclei from
developing or mature mouse cortex, and quantitatively “mapping” RNAs and proteins between these subcellular
compartments. This enabled identification of molecules with subcellular localizations specific to subtypes and
stages, and/or to disease, and measuring of local translation. However, such candidates can function in multiple
subcellular domains, at multiple distinct stages/contexts. Current approaches for whole-neuron perturbation of
molecular abundances produce off-target effects, complicating investigation of subcellular-specific RNA/protein
function, thus preventing elucidation of molecular mechanisms regulating circuit formation and (dys)function.
We aim to develop approaches for subcellular- and stage-/context-specific manipulation of molecular
abundances in developing and mature circuits. In Aim 1, we will develop a system to subcellularly manipulate
RNA/protein abundances in growth cones that regulate distinct developmental stages of circuit construction.
In Aim 2, we will develop a system to subcellularly manipulate presynaptic RNA/protein abundances later in
maturity that regulate synapse function, maintenance, and plasticity, thus are linked to memory, synaptic
weighting, and circuit function. We will employ presynaptic-localizing motifs in mature circuits. These systems
will enable elucidation of subcellular mechanisms controlling circuit formation and function; investigation of
how subcellular dysregulation might cause developmental, degenerative, and neuropsychiatric disorders; and
potentially toward novel therapeutics– circuit- and subcellular domain-specific, to minimize off-target effects.

Public health relevance
NARRATIVE / RELEVANCE: The cerebral cortex, where high-level sensory and motor processing, cognition, and integrative behavior occurs, contains thousands of distinct types of specialized nerve cells (neurons) to perform such complex tasks; cortical projection neurons (PN) are the class of “long-distance” neurons carrying information within and away from the cerebral cortex to the spinal cord and other brain structures, enabling cortex function. It is only partially understood how specific genes and molecules control how these neurons normally develop or are affected by abnormal development, degeneration, or dysfunction in human disorders, including ALS, spinal cord injury, Huntington's disease, cerebral palsy, intellectual disability, autism spectrum disorders; this work also has relevance for regeneration and drug development, since current genetic analysis systems have major gaps in their abilities. We propose to develop an innovative and unprecedented synthetic biology system to uniquely investigate function of specific genes in specific domains (“growth cones” and “synapses”) that control building of brain and spinal cord circuitry and proper brain function; this work also has potential for development of innovative and uniquely specific therapeutics for a range of developmental, degenerative, and neuropsychiatric disorders, and toward future central nervous system regeneration for acquired injuries like spinal cord injury.